Investigation of cerebellar involvement in AUD

Recent animal studies have provided new evidence that the cerebellum may have a stronger link to the reward
system of the brain than was previously recognized. Direct projections from cerebellar deep nuclei (DN) to the
ventral tegmental area (VTA) have been identified, and stimulation of these cerebellar afferents to the VTA was
found to be rewarding. Such findings raise the possibility that cerebellar dysfunction could contribute
substantially to addiction via a cerebellar influence over VTA. Consistent with animal findings, we have found in
human fMRI preliminary data strong cerebellar and VTA activation in response to alcohol cues relative to non-
alcohol stimuli in patients with alcohol use disorder (AUD) compared to controls, and close coupling observed
between DN and VTA activation. Studying AUD and control participants, this project will address three
important questions. The first is: What is the nature of cerebellar input to the VTA, and how is it perturbed in
AUD? A number of investigations have suggested that when a stimulus is presented, the cerebellum generates
a prediction of events that will follow based on prior associative learning, and then compares predicted and
actual outcomes to generate a prediction error. We hypothesize that these functions are disrupted in AUD. Our
preliminary data show that when an expected stimulus does not occur, a strong prediction error signal in the
form of increased functional connectivity (FC) between cerebellum and its projection target is observed, and
we found an analogous increase in DN-VTA FC, that was abnormal in AUD patients, when alcohol pictures
were presented. In Aim 1, using fMRI and a monetary incentive task, we will investigate if DN-VTA FC reflects
reward prediction and/or positive or negative reward prediction error. The second question is: Is the amount of
activation in brain reward centers that is elicited by alcohol stimuli related to the amount of dysfunction in the
cerebellum? In Aim 2 we will investigate 2 measures of cerebellar integrity to determine their relationship with
the magnitude of alcohol cue related activation in cerebellar, VTA, and other reward structures, and with DN-
VTA FC: (1) The timing of the undershoot of the cerebellar hemodynamic response function (HRF), which has
been found to be correlated with number of lifetime drinks; and (2) classical eyeblink conditioning, for which the
cerebellum is necessary. The third question is: Can abnormal cerebellar activation and FC, as well as alcohol
craving, be reduced by non-invasive cerebellar stimulation? In Aim 3, Using fMRI combined with cerebellar
transcranial direct current stimulation (tDCS) during a cue reactivity task, we hypothesize that in AUD
participants cerebellar and VTA activation will be reduced, DN-VTA FC will be normalized, and alcohol craving
will be reduced. We will examine, using both resting state fMRI and psychophysiological interaction analysis,
the effects of tDCS on FC among important structures of the reward system as well as on DN-VTA FC. These
investigations will lead to a better understanding of the involvement of the cerebellum in AUD, as well as the
therapeutic potential of cerebellar modulation.

Public health relevance
Recent animal studies have provided new evidence that the cerebellum may have a stronger link to the reward system of the brain than was previously recognized, raising the possibility that cerebellar dysfunction could contribute substantially to addiction via a cerebellar influence over reward centers. We will investigate the nature of the cerebellar contribution to reward processing, how this contribution is altered by alcohol use disorder, and the extent to which cerebellar/brainstem dysfunction is related to over-activation of reward centers in individuals with alcohol use disorder. We will further investigate if reducing cerebellar activation to alcohol-related stimuli with cerebellar stimulation will reduce activation in reward centers, and reduce craving for alcohol.